The role of norepinephrine transporter phosphorylation in amphetamine reward

SUMMARY
Substance use disorder (SUD), including use of the psychostimulant amphetamine (AMPH) and its congeners,
is on the rise, especially in the Covid-19 pandemic era. There are no effective medications available for
psychostimulant SUD, likely because of the lack of thorough understanding of the complex neurobiology
underlying the disease. Noradrenergic neurotransmission in the mesolimbic circuit plays a critical role in SUD.
AMPH inhibits norepinephrine (NE) transporter (NET) activity promoting its behavioral effects. NET, a principal
mediator of NE signaling, is regulated by post-translational modifications, such as phosphorylation and protein-
protein interactions. These regulators of NET are impacted by psychostimulants, including amphetamine, in turn
impacting the stimulant and rewarding effects of these drugs. However, to date, post-translational modifications
have not been a focus of investigation in the SUD field. Our published studies over several years demonstrate
that the The258/Ser259 motif, a phospho-site in the NET, plays a pivotal role in regulating AMPH-evoked
behaviors. In this proposal, we explore this novel finding using cutting-edge techniques, including a
phosphorylation-defective NET-Thr258Ala/Ser259Ala mutant mouse model (NET-T258A/S259A), a viral-
mediated brain region-specific blockade of NET-T258/S259 phosphorylation, and recordings of extracellular NE
dynamics in vivo using high-speed chronoamperometry and microdialysis. With these new models and tailored
biochemical, neurochemical, and behavioral studies, the current proposal aims to fill critical gaps in our
understanding of the central role of NET phosphorylation in AMPH-evoked NE dynamics and animal behavior.
As a key mechanism, we have discovered that NET-T258A/S259A mice exhibit genotype- and sex-specific
alterations in AMPH sensitivity in addition to brain-region specific variations in NET function and expression.
Here, we will expand and test our overarching hypothesis that brain region-specific T258/S259-dependent NET
phosphorylation and regulation contributes to sex-specific AMPH-induced behaviors relevant to addiction and
reward. Aim 1 will investigate NET regulatory phenomena including NET phosphorylation and NET subcellular
distribution and protein-protein interactions in the prefrontal cortex and nucleus accumbens to determine the
relationship between T258A/S259A mutant-dependent dysfunction in AMPH-mediated NET regulation and in
AMPH-evoked behaviors. Aim 2 will evaluate brain-region specific roles of T258/S259-dependent NET regulation
in AMPH reward using adult DBH-Cre mice expressing the NET-T258/S259 motif in a NE-terminal specific
manner. Aim 3 will examine the impact of T258/S259-dependent NET phosphorylation and regulation on NE
dynamics (release and clearance as well as extracellular levels) modulated by AMPH in vivo. Outcomes from
proposed studies will provide novel insights into the mechanisms of SUD, open new avenues for examining
T258/S259-phosphorylation dependent NET regulation as an underlying mechanism of AMPH’s actions and
provide new molecular therapeutic intervention points.

Public health relevance
NARRATIVE Use of amphetamine and its congeners is currently higher than ever before, surpassing that of all other illicit substances. Substance use disorder, particularly to psychostimulants like amphetamine, is a serious problem in today’s society, compounded by lack of effective therapeutics to treat psychostimulant addiction. This proposal examines the potential of targeting a molecular mechanism, phosphorylation/regulation of the norepinephrine transporter, to reduce the rewarding effects of amphetamine and drug-seeking behavior.